Hereditary Genetics of Hepatocellular Carcinoma

PROJECT SUMMARY
Hepatocellular Carcinoma (HCC) is a devastating and prevalent cancer of the liver with high rates of mortality.
Major risk factors include chronic viral infection (hepatitis B or C), fatty liver disease, alcohol use, and exposure
to environmental toxins. A family history of HCC raises the risk by more than 2.5-fold. The parent R01 grant will
conduct genetic association studies that are powered to detect clinically meaningful germline variants linked to
HCC, and will examine predictors of hereditary cancer syndromes in HCC including age of onset and family
history of cancer. It also explores the mechanism of HCC arising from defects in HR-DDR genes, and will
determine the implications for targeted therapies. In this Diversity Supplement, we request additional funding to
support the thesis work for the graduate trainee. Her proposed work falls within the scope of the parent grant. In
this project, we have completed a CRISPR activation screen in mice livers of genes that are upregulated in
human HCC. We found that upregulated Clk2 expression can drive the development of HCC. CLK2 is a gene
involved in splicing that has been found to be a driver in a number of solid cancers, and early work with inhibitors
looks promising. We hypothesize that CLK2 promotes HCC via the WNT/β-catenin pathway and that CLK2
inhibitors could prevent HCC development. We propose to address this hypothesis with the following aims: Aim
1 will investigate whether CLK2 is required for tumorigenesis by performing pharmacological and CRISPR
targeting of this genes in HCC cell lines and in vivo models; Aim 2 will examine whether the mechanism of CLK2
in driving tumorigenesis is by binding SRSF1 and SRSF3 to influence alternative splicing. These innovative
studies of the genetics of HCC have the potential to personalize therapies for the subset of patients with HCC.
The mentee will have a mentorship team of experts in HCC, hereditary genetics, and animal models to complete
this investigation. This study has the potential to impact on the care of patients with HCC in the US and worldwide.

Public health relevance
PROJECT NARRATIVE This is a diversity supplement request to support the training and development of a graduate student on a project that falls within the scope of the parent project, which examines new ways to potentially treat Hepatocellular Carcinoma (HCC) by identifying new genetic targets in patient subsets. HCC is a devastating cancer of the liver with well-defined environmental risk factors, but with poorly defined genetic components. In this supplement, we will determine the mechanism of the gene Clk2 in driving HCC, and whether targeting this gene can prevent cancer formation.